Metformin BenefIts Lower Extremities with Intermittent Claudication (MOBILE_IC)

Peripheral arterial disease (PAD) is a state of chronic systemic inflammation and atherosclerosis that
results in the narrowing or occlusion of peripheral arteries, most commonly involving the legs. PAD affects up
to 20% of older adults and is especially prevalent among Veterans due to a high rate of smoking. Nearly 90%
of those with PAD suffer from intermittent claudication (IC), defined as reproducible muscle pain with activity
due to reduced blood flow and is relieved with rest. Those with IC are at increased risk of cardiovascular (CV)
morbidity and mortality with progressive decline in walking speeds and distance, functional independence, and
health related quality of life (HRQoL). The treatment of IC beings with medical optimization with smoking
cessation, aspirin and statin therapy, and exercise. Pharmacological therapies for IC are minimally effective.
Supervised exercise therapy does improve walking distance and functional status but is not easily accessible,
compliance is low, and the benefits are not durable. Ultimately, surgical revascularization is the only effective
therapy that can reliably improve IC symptoms long-term but is invasive and expensive.
Metformin is an inexpensive, safe, and effective treatment for Type 2 diabetes (DM2). It has numerous
effects that can counteract the reactive oxygen species, systemic inflammation, DNA damage, and
mitochondrial dysfunction that contribute to age related cellular and organ dysfunction. In preclinical studies,
metformin also stimulates angiogenesis and reduces atherosclerotic calcification. Finally, metformin has been
shown to reduce CV specific morbidity and mortality in those with DM2, independent of glucose control. Thus,
we hypothesize that metformin may be an effective treatment for symptomatic PAD. We developed the
MetfOrmin BenefIts Lower Extremities with Intermittent Claudication (MOBILE IC) Trial to evaluate the effect of
metformin on functional status, PAD progression, systemic and vascular inflammation, neutrophil extracellular
traps, exosomes and microRNAs, and mitochondrial function in nonDM2 Veterans with symptomatic PAD. The
trial is a quadruple-blind, phase 3, single institution, randomized controlled trial which was developed with
Veteran input and is based on patient centered outcomes. A total of 200 male and female Veterans with
symptomatic PAD being evaluated at the VA Pittsburgh (VAPHS) vascular clinic will be stratified by maximum
walking distance (MWD) on the 6-minute walk test (6MWT) and randomized 1:1 to 6 months of 1000mg of
Metformin ER or placebo daily. This trial has 80% power to determine the effect on the primary outcome of
MWD on the 6MWT at 6 months. Secondary outcomes include validated assessments of overall functionality,
general and disease specific HRQoL, subclinical and clinical PAD progression (ankle brachial index, pulse
volume recordings, and endothelial function by EndoPAT), changes in systemic inflammatory markers and
systemic mitochondrial efficiency and health in peripheral blood mononuclear cells. All functional and clinical
outcomes will be measured at baseline, at 6 months of study drug exposure, and 6 months following the
cessation of study drug. Inflammatory and mitochondrial changes will be evaluated at baseline, at 3 and 6
months of drug exposure, and 6 months following cessation. Continuous variables, including the primary
outcome, will be analyzed using linear mixed-effects model analysis with a fixed treatment assignment and
covariate adjustment for the baseline value. Each of the secondary outcomes best summarized as time-to-
event outcomes will be reported using Kaplan-Meier analysis, log-rank tests, and Cox proportional-hazards or
Fine-Gray models to estimate the difference between treatment groups. Primary analyses for treatment group
comparisons will use an intention-to-treat approach and significance will be determined at an 𝛼 level of 0.05
will be used. The success of the MOBILE IC Trial would support Metformin as an effective, safe, and
inexpensive therapy for PAD that may also have effects on concurrent CV diseases and diseases of aging.

Public health relevance
Peripheral arterial disease (PAD) affects over 20% of aged adults and is very common among Veterans due significant tobacco use. PAD is due to the progressive blockage of peripheral arteries, predominantly to the legs, and results in intermittent claudication (IC) or recurrent muscle pain with activity secondary to insufficient blood supply. Those with PAD and IC experience a progressive decline in walking and poor quality of life. There is no effective medical treatment for PAD and IC. Metformin is a safe and effective treatment for Type 2 diabetes but it can also reduce inflammation, oxidative stress, and improve energy requirements as well as improve blood flow to the legs. Therefore, we will test the ability of Metformin to improve overall functional status, reduce PAD progression, and reduce systemic inflammation in Veterans suffering from PAD and IC in a randomized, placebo controlled trial: Metformin BenefIts Lower Extremities with Intermittent Claudication (MOBILE IC) Trial. The success of this trial may identify a safe and effective treatment for PAD and IC.